SOLVENT DEPENDENCE OF ELECTRON TRANSFER IN BIANTHRYL

Dependent on polarity and dynamics of the coherent, fluorescence of bianthryl may occur from two excited state, which differ.substantially in lifetime and spectra. Locally excited (#) and charge transfer (CT) . We observed that in glycerol and especially in glycerol water moistures the bianthryl emission is substantially quenched. We attempt to resolve the origin of these quenching: whether it is static and associated with probe aggregation, or if is due to electron transfer to the solvent.